Development and Translation of D-glucose as a Diagnostic Agent for MRI of Cancer

PROJECT SUMMARY/ABSTRACT
Annually, about 50,000,000 doses of synthetic gadolinium imaging contrast agents are injected into
patients worldwide when getting an MRI. While these agents are extremely safe, they have the potential for
adverse effects in some patients. Also, they may accumulate in brain and bone tissues when a procedure is
repeated, with yet unknown risks. Currently, all MRI agents require some kind of chemical labeling, i.e. with
para- or ferro-magnetic metals or, recently, with hyperpolarized magnetic isotopes. The overall goal of this
BRG is the development of simple D-glucose as an MRI contrast agent. Advantages of using such a natural
agent are safety, absence of interference with contrast on standard anatomical images, low cost, and the
ability to perform repeated studies over a short period of time. We will first develop this technology for brain
cancer, after which it can be adjusted for general use. Contrast agents are used to visualize tumor anatomy
and physiology, which can provide information on malignancy and the response to treatment. Our hypothesis is
that D-glucose as an infusible MRI contrast agent can provide information on three important aspects of tumor
physiology, namely delivery, uptake (including effects of blood brain barrier disruption), and metabolism. If our
developments are successful, translation to clinical application will be fast since D-glucose is already widely
used for other indications (e.g. glucose tolerance test for diabetes), and its safety profile is well established.
Our preliminary data show MRI detectability of D-glucose at millimolar concentrations in animal models at
11.7T and in brain tumor patients at 7T and 3T. However, there are technical issues at 3T due to the reduced
effect size, requiring additional technology development for motion correction, data acquisition, and analysis.
Our overall development goal for this BRG is to optimize and standardize the use of D-glucose as an infusible
contrast agent for diagnostic and prognostic imaging of tumor physiology at the clinical field strength of 3T. The
specific aims are (1) Design and optimize fast whole-brain dynamic MRI saturation pulse sequence technology
to detect D-glucose based (a) T2 relaxation effects, (b) combined chemical exchange saturation transfer
(CEST) and T2 relaxation effects; (2) Design and optimize CEST-MRI-compatible motion correction methods
for dynamic scanning including navigator echo guidance and deep learning analysis; (3) Design and optimize
semi-quantitative and quantitative data analysis approaches for visualizing tumor enhancement and obtaining
indicators of tumor D-glucose delivery, uptake, and metabolism; (4) Standardize the methods of aims 1-3 and
demonstrate repeatability and reproducibility to conclude the work with a clinical MRI protocol for dynamic
glucose-enhanced (DGE) MRI. To accomplish these aims with optimal efficiency, proper validation and clinical
relevance, we have established a multidisciplinary team of experts in the fields of MRI physics (pulse sequence
development), clinical oncology, biostatistics, and endocrinology, which will employ the facilities of several
Resource Centers available at Kennedy Krieger Institute and Johns Hopkins University.

Public health relevance
PROJECT NARRATIVE Annually, about 50,000,000 doses of synthetic gadolinium imaging contrast agents are injected into patients worldwide when getting an MRI scan. While these agents are extremely safe, they have the potential for adverse effects in some patient populations, which may accumulate when a procedure is repeated. We propose to develop the use of sugar (D-glucose) as a biodegradable contrast agent for imaging tumor physiology with MRI; we will first develop and translate this approach for brain cancer, after which the technology can be adjusted for use in other cancers and other disorders.